Supplement to Resolving ensemble averaged conformations by multi-temperature x-ray crystallography - Equipment 2020

The abstract of the funded parent award is contained in the 2 page Research Strategy attachment required under NOT-GM-20-013. (See Research Strategy Section).

Public health relevance
See Research Strategy Section, for project narrative.